Resilience mechanisms of Arctic ground squirrel neurons

Dr. Singhal's long-term goal is to be a VA physician investigator, elucidating mechanisms of neuronal
bioenergetics in order to improve outcomes for veterans with acute brain injuries and other neurological diseases.
The mechanisms linking cellular bioenergetics and cell death in ischemic brain diseases such as stroke are
incompletely understood, and a greater understanding of these details will lead to the development of urgently
needed neuroprotective agents for Veterans. During the Career Development Award-2 period, Dr. Singhal's goal is
to acquire the training and implement the studies needed to understand and develop novel treatment strategies for
conditions he treats in the Neurointensive care unit such as stroke. As such, he proposes a training program
focused on identifying the mechanisms underlying the dramatic ischemia tolerance observed in one of nature's most
resilient animals, the Arctic ground squirrel. Through comparative genomics and cell resilience-based cDNA
expression screens, he discovered unique amino acid substitutions in cytoprotective proteins conferring increased
resilience to metabolic stressors. The research proposed will build on his preliminary data and bring two candidate
genes forward for rigorous study in neural cells using metabolic and cell death assays, visualization techniques, and
biochemical measurements. He will use CRISPR-Cas9 knock-in technology to precisely edit the genes of interest,
which are not fully characterized to date, and study the effect of their editing on neuronal cell resilience (Aim 1) and
elucidate their cell physiologic mechanisms of action (Aim 2). Finally, he will test the candidate genes in the
transient middle cerebral artery occlusion stroke model in vivo (Aim 3). The in-depth characterization using in vivo
and in vitro models will establish a critical connection between the Arctic ground squirrel cytoprotective proteins and
neuroprotective mechanisms, and importantly, provide valuable insights into novel drug targets. Dr. Singhal has
assembled a diverse mentorship team comprised of experts in the fields of stroke, genetics, statistics, and
mitochondrial physiology. Dr. Singhal's career development plan includes a clear timeline for individual tutorials with
mentors and scientific advisors, hand-on experience, formal seminars, dissemination of findings, and plans for
independent projects and funding. The mentored research and training in gene editing, neurovascular biology,
mitochondrial physiology, and statistics described in this proposal will complement Dr. Singhal's training and
facilitate his goal of launching an independent research career at the VA.

Public health relevance
Stroke is a major cause of morbidity and mortality among Veterans in the United States, and results in permanent brain injury due to a lack of blood flow. I have studied the genetics of one of nature's most resilient animals, the Arctic ground squirrel, which survives extreme environmental conditions as well as dramatically reduced blood flow as a natural part of hibernation. I aim to discover precisely how adaptations in Arctic ground squirrel proteins can help brain cells survive a stroke.